Precision Medicine for Chronic Pain: Using Brain Stimulation to Identify and Test Network Biomarkers for Pain Relief

PROJECT SUMMARY / ABSTRACT
Chronic pain is the leading cause of disability worldwide, yet effective treatments remain elusive for most chronic
pain syndromes. Chronic neuropathic pain, resulting from a lesion or disease affecting the nervous system,
produces central sensitization and maladaptive plastic changes across distributed pain processing circuits.
Consequently, there is an urgent need to understand how targeted brain stimulation can influence these
widespread pain networks. My overarching career goal is to become a clinician-investigator with an independent
computational neuroscience laboratory dedicated to studying relationships between brain network organization
and chronic pain. I aim to leverage this knowledge to develop safer and more effective personalized treatments
for chronic pain. The K23 award will provide critical support, mentorship, and training in 4 areas crucial to the
success of my future independent research program, including: (1) advanced functional magnetic resonance
imaging (fMRI), network neuroscience, and machine learning methods; (2) non-invasive brain stimulation with
repetitive transcranial magnetic stimulation (rTMS); (3) clinical trial design, management, and statistics; and (4)
experimental pain research. The proposed research applies this training to fMRI and multimodal pain outcomes
data collected from ongoing trials of rTMS at the primary motor cortex (M1), provided as a therapy for chronic
neuropathic pain. Although M1 is an established rTMS target for pain, clinical outcomes are variable and
unpredictable. I hypothesize that chronic pain results from hyperconnected brain networks and that targeting
highly connected network hubs within M1 can improve network function and reduce pain. To test this hypothesis,
I will first perform a retrospective analysis of data from a pilot clinical trial comparing high frequency excitatory
and low frequency inhibitory rTMS at M1 to examine the relationship between pain relief and the "hub-ness" of
the stimulated target (Aim 1). I will then test whether pain-relieving high-frequency M1 rTMS reduces
pathologically hyperconnected global brain networks (Aim 2). Finally, to prospectively validate network hub
stimulation as a pain-relieving intervention, I propose a new, randomized, controlled cross-over trial comparing
high frequency rTMS at personalized hubs versus non-hubs within M1 (Aim 3). Successful completion of this
study will identify and prospectively validate regional and global network characteristics associated with pain
relief from M1 rTMS. Planned analyses will establish tools and methods capable of predicting new, personalized
rTMS targets in future patients with chronic pain. Results will be used in NIH R01 and HEAL grant applications
for funding to support the ongoing development and implementation of personalized pain-relieving interventions,
to provide much needed alternatives to opioid-based analgesia. Collectively, this training and research will
position me as a global leader in the development of personalized, non-invasive, brain-based therapies for pain.

Public health relevance
PROJECT NARRATIVE Chronic neuropathic pain is highly prevalent and challenging to treat, with current therapeutic options limited by inefficacy and poor mechanistic specificity. In this application, I propose a circuit-based approach—applying advanced network neuroscience methods to functional magnetic resonance imaging (fMRI) and multidimensional pain report data from a unique population of chronic neuropathic pain patients undergoing therapeutic brain stimulation—to determine whether the network properties of the stimulated region predict pain relief, and whether stimulation targeting network hub regions improves global measures of network organization. Data and methods from this study will be used to generate fMRI-based targeting algorithms for personalized, network-informed brain stimulation in patients with chronic neuropathic pain.